BIOCHEMICAL STUDIES ON ANIMAL MODELS OF BATTEN DISEASE

Specific aims are 1) to investigate the relationship between the accumulation of dolichyl oligosaccharides in the brain from canine and mouse models of neuronal ceroid-lipofuscinosis, at the stage of disease progression and 2) determine the nature of the post-translational modification present on either or both of the two forms of mitochondrial ATP synthase subunit c that are accumulated in mnd mice in characteristic storage bodies.